Novel antimicrobials to combat Gram-negative bacteria

Project Summary
Drug-resistant Gram-negative pathogens such as Escherichia coli and Klebsiella pneumoniae are life-
threatening and challenging to eliminate. It is stunning that they could avoid the killing of even colistin, the last
resort antibiotic against these pathogens. While a comprehensive strategy is needed, the development of novel
antimicrobials remains an important element. The objective of this project is to discover novel antimicrobials
that can effectively eliminate drug-resistant Gram-negative pathogens that escape the killing of conventional
antibiotics. Antimicrobial peptides are important candidates and some (e.g., daptomycin and gramicidin) are
already in clinical use. However, it is not yet clear how to choose a promising template for antimicrobial
developments. This project takes a new avenue to peptide discovery by combining our unique database tool
with structural biology. The antimicrobial peptide database is an original resource established and maintained
by the PI’s laboratory for over a decade. To facilitate our development, we have established universal peptide
classification methods, set up criteria for peptide registration, developed the database filtering technology, and
discovered a novel concept for peptide design. As exciting preliminary results, we have identified verine,
which killed resistant bacteria, disrupted preformed biofilms in vitro and showed systemic efficacy in vivo
against colistin-resistant Klebsiella comparable to doripenem. Remarkably, verine possesses a novel
amphipathic structure, entirely different from the classic amphipathic helical structure. We hypothesize that
verine is potent against antibiotic-resistant Gram-negative bacteria; structure-activity relationship, ADME
(absorption, distribution, metabolism, excretion)-toxicity, pharmacokinetic/pharmacodynamics (PK/PD) studies
and in vivo efficacy evaluation in different animal models will improve our knowledge and expand its
therapeutic potential. To test our hypothesis, we have designed the following specific aims: (1) Elucidate the
structure-activity relationship, test antimicrobial susceptibility of verine against Gram-negative pathogens in
vitro alone or in combination with antibiotics and study the genetic basis of bacterial response; (2) Investigate
the in vitro and in vivo toxicity and pharmacokinetic properties of verine and D-verine; and (3) Evaluate efficacy
of verine against antibiotic-resistant Gram-negative pathogens in murine models. We are in an excellent
position to pursue this project. Our preliminary results for each Aim support the feasibility of this project. To
provide complementary expertise, the PI has assembled a strong team with expertise in bioinformatics,
structural biology, peptide chemistry, antimicrobial assays, mechanism of action, microbiology, animal models,
PK/PD, pathology, immunology, and industrial antimicrobial development. The completion of this project will
foster new ideas to combat antimicrobial resistance, substantially improve our understanding of antimicrobial
capability, PK/PD and in vivo efficacy of the novel peptide verine and its analog against various Gram-negative
pathogens.

Public health relevance
Project Narrative Gram-negative pathogens are more challenging to eliminate than Gram-positive bacteria. As preliminary results, we have constructed the antimicrobial peptide database and developed the database filtering technology to design a novel candidate entirely different from classic amphipathic helical structures. The objective of this project is to evaluate structure-activity relationship, antimicrobial susceptibility, PK/PD, and in vivo efficacies of a novel antimicrobial lead against drug-resistant Gram-negative pathogens (e.g., Escherichia coli and Pseudomonas aeruginosa).